FDA Vet-LIRN Site Application - Tier I Lab Renewal

PROJECT SUMMARY
The Veterinary Medical Diagnostic Laboratory (VMDL) at the University of Missouri (MU) is a full-
service for all animal species diagnostic laboratory and it is Missouri’s only laboratory accredited by the
American Association of Veterinary Laboratory Diagnosticians (AAVLD). The VMDL is a Tier I
Laboratory of the Food and Drug Administration (FDA) Veterinary Laboratory Investigation and
Response Network (Vet-LIRN). In addition, the VMDL is a Level I Lab of the National Animal Health
Laboratory Network (NAHLN). The VMDL provides in-depth laboratory diagnostic support to MU
Veterinary Teaching Hospital, non-MU veterinary practitioners, livestock and poultry industry,
stakeholders in companion animal health, wildlife conservationists, and state and federal regulatory
agencies. The goal of this application is to maintain the VMDL’s strong support to FDA Vet-LIRN
mission in investigating potential adverse events affecting the nation’s food or animal feed supply by
testing veterinary products, animal feeds or diagnostic samples. The specific aims are to
1). participation in FDA/Vet-LIRN sample analysis, 2). provide analytical data to support potential
regulatory use, and 3). participate in additional projects, such as method development and validation as
determined by the VPO. The infrastructure funding will enable the VMDL to better support FDA
CVM’s capacity and capability to conduct case investigations.

Public health relevance
PROJECT NARRATIVE Veterinary diagnostic laboratories play significant roles in safeguarding animal and public health by providing diagnostic services, responding to disease outbreaks, developing new testing methods and protocols, and advocating relevant governmental regulations. Protecting and advancing veterinary diagnostic infrastructure and coordination of Vet-LIRN member laboratories, such as the MU VMDL, will strength FDA CVM’s mission of promptly responding to high priority microbial and chemical contaminations of feed and veterinary drugs as well as the transmission of antimicrobial resistance from animals to humans.